Research Capacity Core

Modified Project Summary/Abstract Section

North Carolina Central University’s (NCCU) RCMI Center for Health Disparities Research (RCHDR) was created in September 2017 and includes a Research Infrastructure Core (RIC) aimed at building and enhancing biomedical research infrastructure at NCCU. In last 4 years, RIC has responded to the needs of researchers and suggestions by our advisory committees to develop basic, behavioral and population health infrastructure. In its first cycle, RIC provided support for 3 full projects, 6 Investigator Development Core (IDC) funded pilot projects, 24 additional (non-RCHDR) seed grants and over 20 NIH-funded projects. The RIC also added new capabilities in analytical, imaging, metabolic analysis, and rodent behavior studies, as well as creating multiple biomedical and behavioral -focused programs in data science, health communications, and environmental risks. To maintain and expand our health science research activities at NCCU, RCHDR proposes to continue building our research eco-system through the redesigned Research Capacity Core (RCC). RCC will further enhance our resources in both basic biomedical and behavioral sciences; and lay the groundwork for NCCU researchers to conduct population and health services research pilot studies. RCC will also integrate strategic collaborations with NIH- funded Centers at area institutions and other RCMI centers (through the RCMI coordinating center) to increase our research capacity in biomedical, behavioral, and health-related research.

Public health relevance
Modified Public Health Relevance Section Persistent gaps in access to quality care among U.S. communities contribute to worsening health outcomes and remain a critical public health challenge. The role of HBCUs in addressing and being represented in the community has proven to be essential to address health challenges through research and community engagement. Through this competitive renewal, NCCU's RCMI Center for Health Disparities Research (RCHDR) will continue enhancing NCCU's research ecosystem to develop successful scientists conducting impactful and cutting-edge research that aim to improve health outcomes for all populations.